Fentanyl and Xylazine Interactions: Toxicity Produced by "Tranq-Dope"

PROJECT SUMMARY
Recently, both the Center for Disease Control and the US Drug Enforcement Administration identified
xylazine-adulterated fentanyl as a significant public health threat; however, very little empirical research
has been conducted on this drug combination. Forensic medical reports describe the increasing
prevalence of these drugs in both fatal and nonfatal opioid overdoses, but we are not aware of any
prospectively designed clinical studies describing the toxicity of these drugs. Complicating matters
further, there are no pharmacological rescue interventions for this drug combination, other than anecdotal
reports that naloxone is only minimally effective at reversing overdoses. A final complication is the
emergence of new fentanyl analogues and new alpha 2 adrenergic (α2A) agonists in DEA seizures for
which even less is known. The goal of this project is to collect data on this public health threat that will
be of immediate use to clinicians, scientists, and public health officials. Aim 1 will quantify the interactions
between intravenously administered mu opioid receptor (MOR) agonists and α2A agonists on measures
of cardiorespiratory functioning (i.e., heart rate, respiratory rate, O2 saturation). Aim 2 will quantify the
reversal of these cardiorespiratory effects by potential rescue medications comprising opioid and α2A
receptor antagonists. Importantly, the interactions between several novel MOR and α2A agonists that
have been identified in recent DEA seizures but have not yet been examined experimentally will be
tested. This project should provide critical information to scientists and clinicians about the effects of
fentanyl-xylazine interactions that contribute to lethal overdoses, as well as identifying potential rescue
medications that may be examined in future clinical trials.

Public health relevance
PROJECT NARRATIVE Xylazine-adulterated fentanyl was recently identified as a public health threat to the United States; however, very little is known about the interactions between these two drugs. This project will examine the cardiorespiratory effects of these and similar drugs to better inform scientists, clinicians, and public health officials about the toxicity resulting from these types of drug combinations. Furthermore, the project will examine the effectiveness of potential rescue medications to reverse the cardiorespiratory effects that contribute to the toxicity associated with fentanyl and xylazine.